Optimization of GPCR-based fluorescent sensors for large-scale multiplexed in vivo imaging of neuromodulation

Neuromodulators regulate addiction, attention, cognition, mood, memory, motivation, sleep, and more through
their influence on brain circuits. Classic tools for measuring neuromodulation in the brain have poor spatial and
temporal resolution. This has hampered the discovery of the diverse and complex functions neuromodulation
plays during behavior. Over the past few years, new indicators for imaging neuromodulator dynamics have
begun to dismantle these barriers. However, all existing neuromodulator indicators have significant limitations.
The goal of this proposal is to optimize our GPCR-activation-based (GRAB) genetically-encoded fluorescent
indicators of four major neuromodulators: dopamine (DA), acetylcholine (ACh), norepinephrine (NE), and
serotonin (5-HT). We will make their responses bigger and more specific, create red versions for multiplexed
imaging, and make them easier for end-users to successfully deploy in vivo.
In Aim 1, we will optimize GRAB indicators for DA, ACh, NE, and 5-HT by iteratively screening libraries via
high-content confocal imaging and FACS. We will vary insertion site, linkers, cpGFP, FP-GPCR protein surface
interface, and thermostabilizing GPCR residues on a range of chimeric GCPR sensor backbones. Library
generation will be prioritized by computational prediction of function from GPCR structures. The dimensions of
optimization will be brightness, dF/F0, ligand selectivity, affinity, and non-disruption of endogenous signals. Top
hits will be validated following long-term expression in mammalian brain slice and behaving mice. Our targeted
performance levels are: 1000x ligand selectivity across all neuromodulators (3rd gen), >5x SNR improvement
over 2nd generation indicators in vitro and in vivo (3rd gen), and reliable single-trial subcellular resolution of
graded responses with in vivo 2-photon imaging of cortex during behavior for all neuromodulators (4th gen).
In Aim 2, we will use the same approach as Aim 1 to develop and validate in vivo 1st and 2nd generation red
GRABs for the same neuromodulators to enable simultaneous imaging of multiple signals. Our targeted
performance levels for second generation, spectrally orthogonal red GRABs are 10x dF/F in vitro, >50% dF/F
in vivo responses. We will also engineer out any photoactivation of red GRAB fluorescence, demonstrate
multiplexed imaging and optogenetic stimulation with zero opsin excitation crosstalk from imaging light.
In Aim 3, we will optimize GRAB packaging and distribution for maximum end-user ease of use. We will
quantify the best FPs for in vivo coexpression with GRABs, engineer viral-genetic strategies for robust, brain-
wide GRAB expression from systemic AAV injection, and make cre-reporter mouse lines for the best green
GRAB of each neuromodulator. Optimized plasmids, AAVs, and mice will be broadly disseminated.
Successful completion of our Aims will yield an optimized suite of powerful molecular tools packaged for
maximum utility and ease of use. Since these probes are well-suited for a large number of investigators, they
will have a multiplicative impact on our understanding of neural circuit function and dysfunction.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will optimize a powerful platform of genetic tools for chronic, large-scale, non-invasive imaging of neuromodulation in the brain during behavior. This is relevant to NIH’s mission because these tools will permit new classes of experiments that reveal the role these important molecules play in regulating addiction, attention, cognition, mood, memory, motivation, and sleep, and how aberrant neuromodulation causes many neurological disorders.